Optic nerve head astrocyte sensitivity to glaucomatous insult

PROJECT SUMMARY/ABSTRACT
Elevated intraocular pressure (IOP) is a major risk factor for optic nerve damage in glaucoma. Perplexingly, optic
nerve sensitivity to IOP varies widely across individuals. The overarching goal of this proposal is to investigate
fundamental mechanisms that drive optic nerve sensitivity to IOP. IOP elevation induces pathologic
biomechanical strains on the optic nerve head (ONH). Our previous work identified astrocytes within the ONH
as key sensors of IOP-related biomechanical strain. We recently engineered a 3D hydrogel system to precisely
quantify the response of ONH astrocytes to pathologic biomechanical strains. Our preliminary data using this
innovative system support that pathologic biomechanical strains induce similar ONH astrocyte dysfunction in
vitro as IOP elevations do in vivo. They undergo process retraction and dysregulate oxidative phosphorylation
and mitophagy pathways. We additionally identified the mechanosensitive channel Piezo1 as a key sensor of
biomechanical strain. In the current proposal, we aim to use a combination of cutting-edge 3D bioengineering
tools, transgenic animal models, and ex vivo donor ONH tissue, to test our central hypothesis: Transient
biomechanical strains prime ONH astrocytes to develop greater glaucomatous morphologic and mitochondrial
dysfunction via Piezo1 activation. We propose the following specific aims:
Aim 1: Determine to what extent ONH astrocytes integrate transient biomechanical strains to predispose to
future glaucomatous dysfunction.
Aim 2: Determine if transient biomechanical strains predispose ONH astrocytes to lactate dysregulation and
mitochondrial dysfunction.
Aim 3: Determine if ONH astrocyte Piezo1 regulates ONH astrocyte sensitization and RGC viability in response
to transient biomechanical pre-strains.
The proposed experiments will advance our understanding of glaucomatous optic nerve damage by (i)
determining if astrocytes within the ONH regulate optic nerve sensitivity to IOP, (ii) exploring a mechanistic link
between biomechanical strain, metabolic insufficiency, and ONH susceptibility in glaucoma, and (iii) investigating
if inhibiting mechanosensory pathways will prevent ONH astrocyte priming by biomechanical strain.

Public health relevance
PROJECT NARRATIVE Glaucoma is a leading cause of blindness worldwide. Elevated intraocular pressure is a major risk factor for optic nerve damage in glaucoma, but perplexingly, optic nerve sensitivity to intraocular pressure varies widely across individuals. This proposal aims to investigate mechanisms by which astrocytes within the optic nerve head regulate sensitivity to IOP; the data obtained from these studies will identify new targets to prevent vision loss in glaucoma.